Delaware INBRE Administrative Core

Project summary – Administrative Core
DE-INBRE’s Administrative Core (ADMIN) coordinates the resources needed for the DE-INBRE network to
operate efficiently, runs our Student Research Program (SRP) which provides undergraduates with research
experience, organizes professional development training for students and faculty, and maintains compliance
with all regulations. ADMIN’s leadership team is comprised of the Principal Investigator (PD/PI), Program
Coordinator (PC), the Professional Development and Education (PDE) Director who administers the Student
Research Program (SRP), Evaluation Program (EP) Director who evaluates the effectiveness of all DE-INBRE
programs, and institutional leads from each DE-INBRE network partner institution (NPI). This team is bolstered
by staff who have expertise in grant, SRP, and project administration at both UD (the lead institution) and each
partner institution. Collectively, these personnel, along with the leads of the Data Science (DSC),
Developmental Research Project Program (DRPP) and Centralized Shared Resources (CSR) cores, make up
the DE-INBRE Executive Committee (EC). The EC meets at least monthly to ensure that the diverse
perspectives/needs of network partners are voiced and operating procedures are followed. Thus, DE-INBRE
activities bring broad benefits to organizations as diverse as a community college (DTCC), a Historically Black
College/University (HBCU) and Primarily Undergraduate Institution (PUI) (DSU), a pediatric research hospital
(NCH), a large community hospital system (CCHS), and a Research-intensive flagship university (UD).